Feasibility of an integrated intervention to reduce advanced HIV disease mortality among hospitalized adults in Zambia

PROJECT SUMMARY/ABSTRACT
This is an application for an administrative supplement to a current NIH R34 application that was severely
affected by the Covid-19 (C19) pandemic. The parent award focused on HIV-related mortality in sub-Saharan
Africa. As background, antiretroviral therapy (ART) has been robustly scaled up for HIV treatment in SSA;
however, HIV-related mortality remains unacceptably high. This is often reflected in high prevalence of HIV
among people hospitalized in Southern and East Africa. People with HIV who are hospitalized face high inpatient
mortality (10-25%), but more recently it was recognized that after hospital discharge from the hospital, mortality
remains very high at 25-40%. Overall, within 6 months of a hospitalization, around half of people with HIV have
died, making interventions that can be delivered at the time of hospitalization important. Unfortunately, most ART
programs were designed and are implemented in the outpatient environment and/or the community and do not
consider inpatient settings. Further, inpatient settings pose unique challenges to deliver evidence-based HIV
interventions including the advanced HIV care package. In this R34, we have (Aim 1) developed an approach to
deliver the advanced HIV disease laboratory package to hospitalized people with HIV and (Aim 2) we conducted
qualitative research with inpatient clinicians to understand their perspectives on providing expanded inpatient
HIV care. Because of the C19 pandemic, which disproportionately impacted inpatient settings where we planned
this study, and inhibited human subjects research in general, we are not expecting to complete Aim 3 during this
3-year R34. While we will have some resources for use in a no cost extension, they will be insufficient to pilot
and evaluate the intervention at the heart of this project. Using an administrative supplement, we will enroll a
cohort that is exposed to our intervention, comprised of 3 components: (a) clinician training on advanced HIV
disease care, (b) laboratory approach to make CD4, HIV viral load, and other tests for infections available during
the inpatient stay, and (c) patient navigation to strengthen sample transportation, results return, clinician action
on results, linkage to HIV services at the outpatient clinic, and overall implementation of inpatient care. We will
then assess outcomes, including inpatient implementation of the advanced HIV disease package of care, and
post-discharge re-admission, mortality, and HIV viral load suppression. Outcomes will be compared between the
intervention and observational cohorts. We will also conduct qualitative interviews and focus groups to
understand the feasibility and acceptability of the intervention.

Public health relevance
NARRATIVE This project, focused on development and pilot testing of an intervention for hospitalized adults with HIV to address the problem of post-discharge mortality (which reaches 20-40% within 6 months) in sub-Saharan Africa, is requesting an administrative supplement in order to complete the project, which was severely impacted by the COVID-19 pandemic. With the supplement, an intervention focused on implementation of advanced HIV disease best practices, will be pilot-tested with newly admitted adults with HIV to assess feasibility and change in inpatient clinician practice, with the results informing a future larger-scale evaluation of the intervention.